Effects of Neuromodulation and Cognitive Training on Brain Networks Associated with Relapse in Alcohol Use Disorder

Relapse rates in psychosocially-based treatment programs for alcohol use disorder (AUD) remain high. Novel
brain-based interventions are needed to improve outcomes. Interventions that target the underlying neural
networks associated with relapse hold significant promise in reducing this critical public health problem. My
resting-state functional connectivity (RSFC) data showed that individuals with AUD (i) who have achieved long-
term abstinence have higher prefrontal-striatal RSFC, and (ii) who subsequently relapse show low prefrontal-
striatal RSFC during early abstinence. I am interested in investigating whether prefrontal-striatal RSFC can be
modified during early abstinence as a form of treatment to prevent subsequent relapse. We have evidence that
transcranial direct current stimulation (tDCS) interventions paired with cognitive training can significantly
increase brain RSFC and modify behavior. We will conduct a double-blind randomized trial including 75
participants receiving treatment for AUD to determine whether a tDCS intervention combined with cognitive
training can increase prefrontal-striatal RSFC and reduce amount of alcohol use during a follow-up period. We
will also investigate whether RSFC changes are related to clinical outcomes. The central hypothesis is that
active-tDCS combined with cognitive training will increase prefrontal-striatal RSFC and reduce amount of
alcohol use during a 6-month follow-up period. This research proposal will address the following specific
aims: SA1. Compare the effect of active- vs. sham-tDCS intervention on RSFC. Hypothesis: Active-tDCS,
compared to sham-tDCS will produce greatest increase in prefrontal-striatal RSFC.
SA2. Determine whether RSFC changes during early abstinence affect alcohol use during a follow-up period
(FC changes independent of tDCS intervention). Hypothesis: Degree of prefrontal-striatal FC increases will
correspond to reduction in alcohol use 6-months after intervention. SA3. Compare the effects of active- vs.
sham-tDCS intervention on abstinence over 6-month follow-up period. Hypothesis: Active-tDCS, compared to
sham tDCS will produce lower alcohol use 6-months after intervention. Findings will provide crucial evidence
supporting the therapeutic use of customized brain-based interventions targeting underlying neural
mechanisms to support alcohol abstinence.
T
his research will provide preliminary data for a properly powered
clinical trial, a future R01 application with larger sample sizes and more neuroimaging time points to inform
validated new interventions. Combined with my career development plan and strong mentoring team, this K
award will foster my successful transition to independence as an investigator with the knowledge and skills to
lead a team that converges neuroimaging findings with novel treatment interventions to improve outcomes in
substance use disorders.

Public health relevance
Given high relapse rates, it is crucial to investigate how treatment for alcohol use disorders can be improved. The overarching goal of this proposal is to integrate brain stimulation, cognitive training, and neuroimaging techniques to investigate whether brain networks associated with subsequent relapse can be modified to support abstinence. This research proposal is the first study to examine whether the combined effect of brain stimulation plus cognitive training can affect brain networks during early abstinence in individuals with alcohol use disorder, providing critical information to guide future research and treatment development.